Toward translation of a plant virus-based in situ vaccination nanotechnology

Summary
This R01, submitted to the Toward Translation of Nanotechnology Cancer Interventions (TTNCI) program,
is a continuation of our successful U01 CA218292 (09/2017-07/2022), funded through the NCI Alliance for
Nanotechnology in Cancer program. During the U01 project period, we demonstrated that our nanoparticles
derived from the plant virus cowpea mosaic virus (CPMV) stimulate a potent antitumor immune response against
multiple tumor mouse models. Additionally, trials in companion dogs with melanoma, sarcoma, and breast cancer
demonstrate potent antitumor efficacy with our unique immunotherapy approach. CPMV is an intratumoral
injected in situ vaccine (ISV) technology, with an ability to induce durable immune-mediated antitumor
efficacy against treated and untreated tumors as well as immunological memory against recurrence.
Mechanistically, CPMV activates the innate immune system to improve processing of tumor-associated and
neoantigens, thereby resulting in a more functional adaptive antitumor immunity against antigens expressed by
the tumor. This results in remissions of treated and untreated malignant tumors, and protection from recurrence
via the adaptive arm and immune memory. Building on this strong foundation of data as well as intellectual
property, this project will focus on optimizing GMP manufacturing and pharmacology in murine tumor models
and canine patients to provide the foundational basis of future human oncology trials. The multi-PI leadership
team Steinmetz (UC San Diego), Fiering (Dartmouth) and Ranjan (OSU) brings complimentary expertise in
plant virus-based CPMV nanotechnology, cancer immunology, and veterinary oncology/immunotherapy trials.
Our team is also supported by a group of consultants with expertise in regulatory (Garnick, Mosaic IE Inc.),
pharmacology/toxicology (Luksic, Intrinsik), clinical (Garovoy, Mosaic IE Inc.) affairs, as well as experience
in vertical farming (Eisenberg, OPO). We believe that our strong team of collaborators can help establish the
future manufacture of the plant-derived biologic. We will fulfil the following Specific Aims: (1) Chemistry,
Manufacturing, and Control (CMC) method development for scalable manufacture and QAC of the CPMV-
ISV, (2) Pharmacology: Determine biodistribution, dosing, and toxicology of the CPMV-ISV drug candidate in
orthotopic and metastatic mouse models of melanoma; and (3) Canine trials: establish dosing and safety in
canine oncology trials in varying tumor types amenable for in situ vaccination (melanoma, sarcoma, and mast-
cell tumor). Through parallel trials in murine tumor models and dog patients, we will identify biopsy or blood
biomarkers for longitudinal monitoring of treatment response. Successful completion would position us for good
manufacturing practice (GMP) production of this plant virus-based biologic nanotechnology and to continue the
developmental path, e.g. through the NCI Experimental Therapeutics (NExT) program, thereby translating the
CPMV-based drug candidate into a human clinical trial and practice.

Public health relevance
Narrative A plant virus nanotechnology-based immunotherapy will be developed against metastatic tumors. Specifically, good manufacturing practices (GMP)-compatible, scalable methods for molecular farming of the nanotechnology in plants will be developed; efficacy, pharmacology and toxicology will be evaluated in tumor mouse models and canine patients to set the foundation for translation into clinical trials and practice. Successful completion would enable GMP manufacture, IND-enabling pharmacology, and First-Time-In-Human trial of the plant virus cancer immunotherapy.